Trio Analysis of Recurrent Pregnancy Loss Integrated Bioinformatics Genomics Study (TRIOS)

PROJECT SUMMARY
Recurrent pregnancy loss (RPL) affects up to 5% of families, yet nearly half of cases remain unexplained after
evaluation by current testing recommendations. Unexplained euploid RPL is particularly frustrating for families
and providers because there is no clear explanation nor proven therapy to mitigate risk of recurrence. As
clinical presentations, subsequent pregnancy outcomes, and underlying etiologies vary widely, this complex
disorder requires a precision health approach. TRIOS, the parent grant, investigates genetic causes of
unexplained recurrent pregnancy loss. Genome sequencing holds immense promise for discovery of genetic
variants that are lethal in humans; however, despite genetic diversity among humankind, it is well-documented
that genetic studies of human disease have historically failed to capture this variation. Repeated
underrepresentation of individuals of non-European ancestry has not only severely limited the understanding of
genetic disease in humans, but has also led to significant ancestry-based health inequities. Conversely,
increased diversity in genomic research has been shown to simultaneously increase genetic discovery and
reduce health disparities. For this reason, concerted efforts to increase racial and ethnic diversity in genetic
research is necessary for discovery and characterization of all disease-causing genetic variants, as well as
providing equitable and personalized care to all. This supplemental proposal aims to explore and implement
novel community outreach, recruitment, and enrollment methods to reduce barriers and increase minority
engagement in the genetic research described in our parent grant. We will engage community physicians and
front-line community healthcare workers through unstructured focus groups to better understand the threats
and opportunities in enrolling their patients in research studies. Financial and transportation barriers will be
minimized by facilitating enrollment and collection of samples by mail. Additionally, we will ensure research
materials are accessible in Spanish, and bilingual staff are available to support families throughout all study
phases. When found, we will provide actionable genetic test results to enrollees, providing personalized and
direct benefit from participation in our research. Importantly, this proposed supplement will provide valuable
insights into best practices for expanding geographic, socio-economic, and ancestral diversity in reproductive
and genetic research. We are uniquely positioned to achieve the aims of this study due to the diverse
population of Northern California, our affiliation with a far-reaching healthcare system, and a research team
experienced in community-engaged research efforts. The proposed supplement is anticipated to enhance and
enrich our recruitment of diverse populations for our parent grant examining genetic causes of RPL through
genome sequencing, multi-omics analysis, and applied machine learning methodologies. This work will
ultimately advance our understanding of RPL, inform human biology, decrease disparities, and allow for
tailored diagnostics, recurrence risks, and novel therapeutics for this devastating and complex disorder.

Public health relevance
PROJECT NARRATIVE Genetic causes of recurrent pregnancy loss are poorly understood, limiting diagnostics, recurrence risk counseling, and development of therapeutics for this devastating and complex disorder. Despite genetic diversity among humankind, genetic studies of disease have historically failed to capture this variation, compromising our understanding of human disease, and resulting in significant ancestry-based health inequities in all disciplines of medicine. The proposed work will provide methods for increasing diversity and inclusion of participants in this important study on genetic causes of pregnancy loss to improve genetic discovery while simultaneously identifying and addressing some of the barriers, gaps, and disparities in current health research.